Assessing the Neuropsychological Benefits of Weatherization Programs

PROJECT SUMMARY
The homes of millions of older Americans do not provide adequate protection from extreme temperatures,
due in large part to “energy poverty.” Modifications to homes that increase energy efficiency and improve
indoor temperatures may reduce the adverse neuropsychological health impacts of extreme temperatures.
Indoor temperatures may impact sleep quality and short-term cognitive function, and high utility bills may
exacerbate the psychosocial stress of financial worry. Some of the health benefits of weatherization have been
previously characterized, including reductions in emergency department visits related to asthma. We propose
to evaluate the health and financial impacts of low-cost and higher-cost weatherization programs, considering
the novel or under-studied outcomes of financial worry, cognitive function, and sleep quality and duration. We
propose to enroll three categories of participants: those of a low-cost weatherization program in a cold climate
(Detroit, MI), those of a high-cost weatherization program in a cold climate (Madison, WI), and those of a high-
cost weatherization program in a warm climate (Memphis, TN). In a longitudinal study with sleep cycle
measurements (actigraphy), multiple surveys and sub-hourly indoor temperature and humidity monitoring per
person over one year of participation, we aim to characterize 1) associations of indoor temperatures with
cognitive function and sleep quality and duration and 2) associations of low- and high-cost weatherization
programs with indoor environmental parameters (temperature, humidity) and financial worry. In aim 3), we will
characterize the monetized health impacts of low- and high-cost weatherization programs in terms of both
community-wide air pollution benefits (related to reduced energy consumption) and recipient-specific health
benefits identified in previous research and any benefits from aims 1 and 2. This research will advance our
long-term objectives of reducing the health impacts of extreme weather, characterizing the health impacts of
the home environment, and reducing disparities in the health impacts of energy generation and use. This
research will inform policies for energy efficiency and weatherization subsidies, considering that medical
savings from expenditures on housing upgrades would potentially reduce state- or federally-subsidized
healthcare expenditures. Such interventions may improve the health of older adults via improvements to indoor
temperatures and reductions in utility costs and help households both mitigate (through decreased energy
usage) and adapt to extreme weather.

Public health relevance
PROJECT NARRATIVE Modifications to homes that increase energy efficiency and improve indoor temperatures may reduce the health impacts of extreme temperatures and financial stress. We will characterize and monetize the health impacts of low-cost and higher-cost weatherization measures, which may improve the health of older adults through improvements to sleep, cognitive function, and financial worry as well as community-wide reductions in air pollution exposure. Weatherization interventions may allow older adults to both mitigate and adapt to extreme weather.